DMNT3A MUTATIONS IN PATIENTS WITH ACUTE MYELOID LEUKEMIA

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The goal of this project is to measure DNA methylation in patients with acute myeloid leukemia (AML) by LC-MRM-MS using published methods and also to identify other DNA adducts.